Research Education Core

The objective of the Research Education Core (REC) is to identify highly promising early-stage investigators
and provide support to promote their development as independent investigators and leaders in aging research.
The REC seeks to provide three groups of investigators, designated as REC Scholars, Small REC Awardees,
and REC Affiliates, with the knowledge and skills to conduct biological, translational, and clinical studies of
multifactorial geriatric conditions and to obtain subsequent funding from a broad range of sources. The out-
comes and career advancement goals for the REC investigators include: 1) publication of research results in
high-impact journals; 2) success in obtaining independent funding, both to support further career development
and specific research projects; and 3) development of leadership skills necessary to manage research teams,
become successful mentors, and assume leadership roles in the OAIC and their departments/divisions.
This renewal application builds upon the successful experiences of the current and prior funding cycles in
nurturing faculty from both geriatric medicine and a variety of medical subspecialties, including both physicians
and PhD investigators. We will expand upon the advances in the current cycle to support investigators pursu-
ing basic and translational research programs, in addition to those pursuing clinical research programs, en-
couraging them to embrace the complexities of multifactorial geriatric conditions. The inclusion of three groups
of REC investigators will allow us to provide support to an expanded group of early-stage investigators. The
REC Scholars will receive (1) the most extensive financial support to protect their time for conducting research
and (2) priority access to the Resource Cores to conduct OAIC-supported projects. The Small REC Awardees
will receive more modest financial support with the goal of developing strong candidates for subsequent REC
Scholar awards or other funding. REC Affiliates will not receive project funding but will have access to all REC
didactic and career development activities. All three groups of REC investigators will receive research and ca-
reer development support in a number of key areas, including: 1) appropriate mentorship in aging/geriatrics,
especially for trainees new to aging research and/or in fields outside of geriatric medicine; 2) a didactic curricu-
lum addressing key skills and knowledge necessary for the study of multifactorial geriatric conditions; 3) a cur-
riculum to support the transition to independent funding and build leadership skills; 4) regular research-in-pro-
gress meetings to present their own work and to learn from the experiences of other early-stage investigators;
5) additional research meetings to learn from more experienced investigators; 6) a day-long career develop-
ment retreat focused on aging-related research; 7) regular updates regarding research meetings, career devel-
opment activities, and funding opportunities both within and outside of Yale; and 8) mentorship and Resource
Core support for the development and writing of larger scale grant applications. We will identify and support a
diverse array of early-stage investigators, including those from under-represented groups.